HIV Reservoir Dynamics and Immune Responses Across the Female Reproductive Life Span

Summary
Efforts towards an HIV cure have elucidated the marked variation in the HIV reservoir and the immune responses
between different individuals. Sex has emerged as a factor that is associated with differences across the
spectrum of HIV from acquisition through pathogenesis and HIV reservoir dynamics. Although the mechanisms
are incompletely defined, the sex steroid hormone 17β-estradiol has been shown to interact with HIV replication
and maintenance of latency. Levels of this hormone vary dramatically over the lifespan, introducing periods of
potential reservoir disruption that are unique to women. In addition, natural aging has sex-specific features, which
may be partially linked to sex steroid hormone exposure, and this has intersections with HIV reservoir
maintenance and immunity. Despite these data, there is a marked underrepresentation of women in studies
relevant to HIV cure. This is in part due to the limited number of cure studies in Africa where the majority of
women living with HIV reside; this has also meant that the majority of virologic assays have not been developed
for non-subtype B viruses. In this proposal, we will address the knowledge gaps around sex-specific features of
HIV reservoir with specific attention to aging across the reproductive lifespan in a cohort of Ugandans living with
HIV.
We will accomplish this with three specific aims:
1. Analyze the impact of pregnancy on HIV reservoir and immunity
2. Assess HIV reservoir and immunophenotype across the menopausal transition in comparison to
chronologically age-matched men
3. Estimate epigenetic age in women and men living with HIV and assess for relationships with sex and HIV
reservoir activity.
We have assembled a multidisciplinary team, led by co-Principal Investigators Dr. Eileen Scully (Johns Hopkins
University) and Dr. Ronald Galiwango (Rakai Health Sciences Program), who together have the expertise and
infrastructure to recruit participants and perform the advanced analyses to accomplish these aims. The study will
substantively advance the understanding of the non-subtype B reservoir in women across the reproductive
lifespan and the intersections between sex, reservoir and aging with multiple potential implications for curative
efforts.

Public health relevance
Narrative Efforts towards an HIV cure have highlighted the interindividual variability in the HIV reservoir and immune responses and have identified sex and age as potential drivers of these differences. In this proposal, we query the impact of key moments across the lifespan including pregnancy, the menopausal transition, and aging with detailed longitudinal characterization of the reservoir and immune phenotype in a cohort of Ugandans living with HIV. These studies will address important gaps in knowledge about reservoir and immune dynamics particularly relevant to the optimization of cure interventions in women living with non-B subtypes of HIV.